Multi-functional cellular therapies to overcome tumor heterogeneity and limit toxicity in acute myeloid leukemia

PROJECT SUMMARY/ABSTRACT
Acute myeloid leukemia (AML) is a devastating disease with only 30% 5-year overall survival. As a blood
cancer, AML appears poised to benefit from the revolution in engineered cellular therapies and bispecific
antibodies. These agents are making an enormous impact in B-cell malignancies. However, extending this
success to AML faces two significant hurdles: 1) lack of highly disease-specific targets, where engaging
current AML therapeutic targets leads to severe cytokine release syndrome and severe myeloablation,
precluding an effective therapeutic index; and 2) significant intratumoral heterogeneity, where targeting a single
surface antigen is likely to lead to antigen-negative relapse. In practice, these two challenges leave few
therapeutic targets sufficient to achieve cures in most patients. Here, my long-term goal is to develop a new
therapeutic approach to overcome these hurdles. This proposal will be led by myself under the sponsorship of
Dr. Arun Wiita, an expert in hematologic malignancies and drug resistance, with collaborative support from Dr.
Kole Roybal, expert in advanced cellular engineering; and Dr. Jim Wells, expert in antibody engineering.
Specifically, I hypothesize that employing SNIPR, the newly-described, next-generation, humanized platform
based on the SynNotch cellular engineering technology (Zhu et al., Cell 2022), will enable development of a
multi-functional T-cell therapy that can eliminate residual AML after induction chemotherapy, clearing relapse-
driving leukemic stem cells and increasing cure rates, while avoiding toxicities of systemic therapeutics. My
major design pillars include 1) develop engineered T-cells that home specifically to the leukemic stem cell
niche; and 2) locally, but not systemically, have SNIPR T-cells secrete multiple protein therapeutics to ablate
heterogenous leukemic stem cells and AML blasts in and near this niche. In Specific Aim 1, I test the feasibility
and initial in vitro and in vivo potency of SNIPR engineered T-cells designed to simultaneously secrete
functional bispecific antibodies against 3 AML targets. In Specific Aim 2, I use PDX models to test whether
SNIPR T-cells can selectively home to the bone marrow niche, with CD70 as the optimal leukemic stem cell
“trigger”. Successful completion of these Aims will set the stage for subsequent work, outside the scope of this
proposal, to validate, using additional in vitro and in vivo models, the ability of CD70-sensing, multi-bispecific-
secreting T-cells to eliminate AML more completely than other therapies while minimizing toxicities.
Furthermore, this approach will ultimately enable delivery of other therapeutic payloads to the leukemic stem
cell niche, ideally targeting this disease-driving cellular population with unprecedented precision. Success here
may also outline a new therapeutic strategy for use across cancers, to eliminate heterogeneous tumor in the
microenvironment while sparing normal cells. Completion of the work in this proposal in conjunction with the
associated training plan will provide critical expertise and experience to support my goal of becoming an
independent physician-scientist focused on translational immunotherapy research.

Public health relevance
PROJECT NARRATIVE Acute myeloid leukemia (AML) is among the deadliest blood cancers, affecting 20,000 Americans per year with a 5-year survival rate of only 30%. While engineering cells of the immune system to target cancer is one of the most promising approaches in treatment today, this approach has been difficult to apply in AML due both to lack of specific targets on tumor cells as well as the fact that many tumor cells may not express a single targeted antigen. Here I aim to perform initial development of a new type of engineered cell that can specifically eliminate the relapse-driving residual tumor cells after initial chemotherapy, with the long term goal of achieving more AML cures with lower toxicity than current approaches.